ED-LEAD: Emergency Departments LEading the transformation of Alzheimer's and Dementia care

PROJECT SUMMARY
In persons living with dementia (PLWD), an Emergency Department (ED) visit is a critical event and an
opportunity to address the unmet needs that preceded the visit. Our multiple PI (mPI) team have together
conducted cluster-randomized, multi-site trials in >50 EDs as well as multiple hospice and home health
agencies, and are uniquely poised to address previous shortcomings in the development of scalable models of
care for PLWD. Through this work, and that of our co-investigators, we have developed and tested three
interventions relevant to PLWD and their care partners who visit the ED: 1) emergency care redesign
(UH3AT009844) of new and intentional workflows for emergency providers reinforced by digital alerts and
structured collaboration between sites, already shown to increase identification of advance care plans and
enlisted multidisciplinary support; 2) a nurse-led telephonic care program (PCORI) that increased advance
care planning and connected patients to hospice; and 3) a community paramedic-led structured coaching
intervention (R01AG050504) that reduced the odds of an ED revisit within 30 days by 75%. Building on this
evidence, the overarching goal of EDs LEading the Transformation of Alzheimer’s and Dementia Care (ED-
LEAD) is to turn an ED visit from a crisis into an opportunity to improve the well-being of PLWD and their care
partners. ED-LEAD will be embedded in a diverse group of 14 health systems, including 80 EDs with
substantial racial and ethnic diversity, with the ED as the unit of randomization. An Administrative Core will
oversee completion of all administrative milestones including integrating expertise and guidance from two NIA-
funded networks and an External Advisory Board. An Implementation Core will: 1) harmonize core functions
and processes; 2) optimize clinical decision support; and 3) and enable intervention fidelity across the three
interventions. Finally, a Statistical Analysis Core will provide biostatistical and data management support. Our
specific aims are to: 1) optimize a concurrently run emergency care redesign, nurse-led telephonic care, and
community paramedic-led transitions intervention in PLWD for feasibility, fidelity and usability in two EDs; 2)
study the effectiveness of these three interventions, alone and in combination, for PLWD with serious illness in
a cluster-randomized multifactorial trial embedded within 80 EDs on: ED revisits, hospitalizations, and healthy
days at home following the index ED visit; and 3) determine site, provider, patient, and care partner-level
characteristics within a diverse population associated with variation in implementation of each intervention. ED-
LEAD will address shortcomings noted in the National Academies of Sciences, Engineering, and Medicine
report on PLWD by providing high-quality, real-world evidence that may improve the lives and reduce suffering
of PLWD and their care partners. It will address key strategic goals of NIA and the National Alzheimer’s Plan to
“implement and evaluate new care models to support effective care transitions”, and provide health systems
with the necessary evidence to scale interventions for this vulnerable population.

Public health relevance
PROJECT NARRATIVE For persons living with dementia (PLWD), and particularly for those with serious illness, an Emergency Department (ED) visit is a critical event and an opportunity to address the unmet needs that preceded this visit. Our multiple PI (mPI) team, who have together conducted cluster-randomized, multi-site trials in >50 EDs as well as multiple hospice and home health agencies, is uniquely poised to address previous shortcomings in the development of scalable models of care for PLWD. The overarching goal of EDs LEading the Transformation of Alzheimer’s and Dementia Care (ED-LEAD) is to turn an ED visit from a crisis into an opportunity to improve the health and well-being of PLWD and their care partners.